Sensitivity to spectral cues in infant speech perception

DESCRIPTION (provided by applicant): The proposed research will examine infants'sensitivity to multiple spectral cues in speech perception. Speech is a complex signal, with numerous acoustic cues for every consonant and vowel. Through experience, listeners learn to exploit correlations between multiple cues, making perception more efficient and robust. Adults display this knowledge through their use of cues that are spectrally local (e.g. formant transitions) as well as distributed (e.g. gross spectral shape, or tilt) to distinguish speech sounds. Although prior research has demonstrated infants'ability to distinguish many speech sounds, how they distinguish these sounds is unclear. Infants'sensitivity to individual cues, the relative importance they assign to each cue, and when they learn to exploit correlations between cues all remain poorly understood. We propose four experiments to address these questions. The first aim of this project is to investigate sensitivity to spectral cues. To address this issue, the first two experiments will examine speech perception when the natural covariance between two cues is violated or maintained. The latter two experiments will test sensitivity to changes in individual cues. The second aim is to assess relative cue salience across the lifespan. Results from the first experiment will be compared to existing data from normal-hearing and hearing-impaired elderly adult listeners who completed a similar task (Alexander &Kluender, in press;in preparation) to assess differential effects of listening experience and hearing health on perception of the same speech stimuli. We hypothesize that both 6-to-7-month-old and 11-to-12-month-old-infants will exhibit perceptual sensitivity to both spectral cues in speech perception, with 11-to-12-month-olds displaying the greatest sensitivity. We also hypothesize that younger infants may be relatively more influenced by spectrally global (e.g. tilt) cues than older infants. Our long-term objective is to better understand development of speech perception in infants with normal and compromised hearing. These results will help refine treatment methods for infants with hearing loss, and inform the use of devices such as hearing aids and cochlear implants. Public health statement: The proposed research will reveal the acoustic information infants use to distinguish speech sounds, and whether this information is used differently by adults. Knowing what infants listen for will benefit efforts to facilitate development of speech perception in children with compromised hearing. This research will also investigate when infants learn to exploit statistical regularities between cues in natural speech.